TRAINING IN LIVE CELL FLUORESCENCE MICROSCOPY AND FRET ANALYSIS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We request training on FRET analysis. We wish to learn all aspects of your approach, from cell growth, slide preparation, microscope set up, data acquisition and data analysis.